Laboratory Animal

PROJECT SUMMARY (See instructions): LABORATORY ANIMAL SHARED RESOURCE The primary purpose of the Laboratory Animal Shared Resource is to provide the resources and environment with which animal models of cancer can be created and analyzed for the Kimmel Comprehensive Cancer Center. This shared resource provides housing and high quality maintenance and care for laboratory animals. The facility also provides technical expertise in small animal surgery, and administration of chemical and radiological reagents. A critical component of the facility is the maintenance of a high quality barrier facility to generate a specific pathogen-free environment that ensures the accurate interpretation of experimental results. The in-colony health surveillance program ensures the fidelity of the facility. The Laboratory Animal Shared Resource has maintained full AAALAC accreditation since 1977. The facility is operated as a partial barrier system in which all animals are housed in sterile ventilator cages on ventilated racks. The facility is composed of 29 animal rooms, along with the requisite cage and food storage area, a dedicated necropsy room, and a tunnel cage washer. This shared resource also provides cryopreservation of valuable mouse strains and recovery of mice from frozen germplasm as well as a range of assisted reproductive techniques that can be applied to maintaining mouse strains in a cost- and time effective manner. This shared resource has consistently maintained the highest level of expertise and proficiency, greatly enhancing the work of Kimmel Cancer Center members. This facility was used by 46 Cancer Center Members.

Public health relevance
RELEVANCE (See instructions): The Laboratory Animal Shared Resource provides the services necessary for the proper care and treatment of animals used for cancer research studies. In addition, the facility provides cryopreservation of sperm and embryos for common and unique mouse mutants that are useful for studies of cancer development and treatment.